The Administrative Core of Prefrontal Cortex, Cognition, and Speech Symptoms in Parkinson’s disease (PRECIS-PD)

Abstract
The Administrative Core of Prefrontal Cortex, Cognition, and Speech Symptoms in Parkinson’s disease
(PRECIS-PD) will facilitate new collaborative projects that will advance our understanding of the
prefrontal cortex (PFC) in cognitive and speech dysfunction in Parkinson’s disease (PD). Led by Dr.
Nandakumar Narayanan (Program Director/Principal Investigator), this core will provide the leadership,
oversight, and project management that will form the organizational basis for the proposed Exploratory
Grant, as well as for a future NINDS Udall Center P50 application. The Administrative Core will promote
research integration and synergies across projects and cultivate communication among our researchers
and our internal and external committees. The University of Iowa will provide funding for a dedicated and
experienced Research Administrator to manage the proposed Exploratory Grant. These efforts will be
heavily buttressed by the outstanding research organizations at UI, including the Department of
Neurology, the Iowa Neuroscience Institute (INI), and the Institute for Clinical and Translational Sciences
(ICTS).
The Administrative Core will provide focus, leadership, and vision for PRECIS-PD, foster open and
effective research communication, develop pipelines for data analysis and data sharing, and ensure our
research is robust, rigorous, and reproducible. This Administrative Core will manage all P20 projects to
collect innovative preliminary data towards supporting a future P50 application. Our focus will be on
communication and organization around high-quality neurophysiological data, and on cultivating an
environment of transformational discovery that will inspire meaningful impact in the lives of PD patients.

Public health relevance
Per the RFA, do not include narrative.